Role of nicotinic receptors in inhibitory GABA neurons on alcohol reward and behavior

PROJECT SUMMARY Excessive consumption of alcohol contributes to 9.8% of preventable deaths annually, and alcohol abuse costs $2.5 billion each year in healthcare and economic expenses. Despite the high costs of alcohol abuse, consumption has increased significantly over the past decade. There are only 3 FDA-approved pharmacotherapies to reduce alcohol use, all with low efficacy in achieving and maintaining abstinence, highlighting the need for more effective treatments for alcohol abuse. One of the major barriers to developing better treatments for alcohol abuse is the multitude of cellular and molecular mechanisms underlying alcohol reward. Recent studies indicate the rewarding properties of alcohol are dependent upon its interaction with nicotinic acetylcholine receptors (nAChRs) in reward pathways. nAChRs in the midbrain reward circuit stimulate dopamine (DA) release, which mediates alcohol reward. The α4 subunit is of particular interest in alcohol addiction, as pharmacotherapies targeting this subunit decrease alcohol consumption in human and animal models. Additionally, α4 knockout mice show reduced alcohol consumption and DA release, and do not reduce their alcohol consumption in response to nAChR drugs. α4 nAChRs are found within several cell types in the ventral tegmental area (VTA), including DA projection neurons and local GABA neurons, which provide inhibitory tone to DA neurons. Recent studies demonstrate that VTA GABA neurons are critical mediators of reward behaviors, as activating these neurons disrupts sucrose consumption and conditions a place aversion. Alcohol increases DA neuron firing frequency, which influences alcohol reward behavior. Alcohol also modulates the activity of VTA GABA neurons, but the role of nAChRs in this process has not been studied. Current approaches in the field cannot probe the role of α4 nAChRs in individual cell populations, and the mechanism through which nAChRs on inhibitory GABA neurons modulate alcohol reward remains unknown. To address this gap in knowledge, we have developed a conditional viral gene delivery strategy that initiates knockdown of the α4 subunit selectively within VTA GABA neurons. The goal of this proposal is to define the role of the α4 nAChR subunit in VTA GABA neurons in alcohol consumption and reward. We hypothesize that nAChRs containing the α4 subunit in VTA GABA neurons decreases alcohol reward and consumption through inhibition of DA neuron excitability. The specific aims of this project include: 1) determine the role of the α4 nAChR subunit in VTA GABA neurons in voluntary alcohol consumption in mice; and 2) determine the role of the α4 nAChR subunit in VTA GABA neurons in the DA neuron-activating and subjective rewarding properties of alcohol. This proposal will provide novel and important information about the role of the α4 nAChR subunit in modulating alcohol reward. By identifying important cell types and nAChR subunits in alcohol reward, the results of this study will provide valuable insight into the development and refinement of preclinical alcohol cessation drugs and thus help address one of the largest public health problems in America.

Public health relevance
PROJECT NARRATIVE Alcohol abuse is a major public health problem with limited treatment options, as current pharmacological therapies have low rates of achieving and maintaining abstinence. We will use a novel technique to delineate the role of different nicotinic acetylcholine receptor subtypes in individual neuron populations in alcohol reward circuitry. Successful completion of this proposal will yield insight into the mechanism of alcohol reward, and inform the development of therapeutic interventions designed to treat alcohol abuse.